A tale of two cities: Understanding geographic differences by region and rurality in HIV care outcomes in the U.S.

The U.S. initiative of Ending the HIV Epidemic (EHE) has fallen short of its goals, and
geographic differences in HIV care outcomes have only widened in the last decade. For
example, here are significant differences in HIV care outcomes, such as viral suppression and hospitalization
rates, among people living with HIV (PLWH) between the Western and Southern regions of the U.S., as well
as among urban centers and rural areas. These geographic differences are also observed in other chronic
diseases, yet, PLWH appear to be at higher risk of poorer health outcomes than persons not living with HIV
(PNLWH), especially in rural areas. These geographic differences are likely largely driven by underlying
factors in our health systems, such as access to healthcare, providers, and specialized care centers in rural
areas—an understanding of these pathways that elucidate these differences is urgently needed to develop
the next generation of HIV interventions operating at the health systems levels, and ever more now in the
context of compounding chronic diseases affecting PLWH.
The National Clinical Cohort Collaborative (N3C) leverages real-world, national data and presents an
unprecedented opportunity to inform the NIH priority aims to understand the factors that affect both HIV and
other chronic conditions. N3C is the largest electronic health record (EHR) repository in U.S. history (>20M
patients), contains both unparalleled individual-level granular clinical and historical data, and represents the
largest U.S. cohort of PLWH with their HIV and other chronic conditions outcomes data (>120K), allowing
us to evaluate the bi-directional impact of existing HIV infection and other chronic diseases outcomes.
Furthermore, individual-level data in the N3C are uniquely positioned to merge publicly available datasets that
measure area-level health systems factors. Our central hypothesis is that the observed geographic differences
in HIV and other chronic diseases occur in a larger context of individuals embedded in health systems with very
significant differences across the U.S., between urban areas as well as between urban and nearby rural areas.
Understanding these forces, allows us to determine the next generation of HIV interventions.
Our three aims respond to the NIH call using data science, rigorous and reproducible machine and
statistical learning, and multi-level mediation and epidemic modeling. The goal of Aim 1 (HIV outcomes) is to
identify multilevel, geographic and health systems differences in HIV outcomes (e.g., viral suppression and
hospitalization) over the recent years. The goal of Aim 2 (chronic diseases outcomes) is to understand the
independent and aggregated impact of geographic differences and clinical characteristics on health outcomes
(2a) and quantify the differential impact of HIV on other chronic diseases outcomes at the U.S. population level
by geography (2b). The goal of Aim 3 (HIV epidemic modeling) is to quantify the impact of other chronic diseases
on HIV care and prevention outcomes by geography at the population-level for the national EHE initiative’s
priority jurisdictions.

Public health relevance
This research will contribute to public health efforts to improve treatment and prevention outcomes for people living with or at risk for HIV in U.S., especially those belonging to rural communities. Findings from this study will have important implications for HIV treatment and prevention approaches as well as other chronic diseases management. This research has the potential to make important contributions towards addressing some of the key public health problems in the U.S., including attainment of the UNAIDS 95-95-95 targets for HIV and addressing geographic differences in health outcomes in the U.S.